Research Training Program in Adolescent HIV in Haiti

This proposal builds on the foundation established in Haiti during three decades of NIH
research and training support to Groupe Haitien d’Etude du Sarcome et des Infections
Opportunistes (GHESKIO) and Weill Cornell Medicine (WCM) to address the burgeoning
adolescent HIV epidemic in Haiti. The focus of this training program is to improve HIV-related
health outcomes of adolescents (10 to 19 years) and youth (20 to 24 years) in Haiti. A major
emphasis is research-training to extend adolescent HIV services from the clinic to the
community. Evidence demonstrates that providing services in the community improves access,
social acceptability, cost-effectiveness, and ultimately large-scale impact.
This program extends graduate level training in Haiti by establishing Haiti’s first PhD
program in Public Health. We build upon an MPH program established in Haiti with prior Fogarty
support. A cadre of 8 Haitian long-term trainees will receive research training – 4 will receive
an MPH and 4 will receive a PhD – the first cohort with doctoral level public health training in
Haiti. The research training will focus on adolescent health in the areas of 1) HIV prevention, 2)
HIV treatment, 3) HIV and TB co-infection, and 4) HIV and NCDs. Trainees will be groomed to
be the future leaders of adolescent health research at GHESKIO and the Haitian Ministry of
Health. The program will also include medium-term training (6-12 months) of research staff
including psychologists (4), data managers (4), and community health workers (4) to establish
community-based research teams.
In Haiti, 50% of all new HIV infections are in adolescents and youth, and 80% of these
are impoverished and stigmatized females. UNICEF has declared adolescents the ‘center of the
HIV epidemic’. HIV-infected adolescents and youth have poor antiretroviral treatment
outcomes with only 50% remaining in care after 1 year, compared to 90% retention among
adults. The period between 10 and 24 years is the peak incidence of TB infection and
disease. Furthermore, only 40% of HIV-infected adolescents with culture-positive TB
successfully complete therapy. Finally the rate of early onset hypertension in adolescents
and youth in Haiti is 12% - 3-fold greater than in similarly aged Black Americans.
The development and validation of community-based approaches to identify, engage, and
retain adolescents and youth in care will lead to sustainable improvements in health outcomes
in Haiti. This program responds to the priorities of the Haitian Ministry of Health and will train the
next generation of Haitian leaders in the conduct of community-based adolescent HIV research.

Public health relevance
The focus of this training program is to improve HIV-related outcomes of adolescents (10 to 19 years) and youth (20 to 24 years) in Haiti by providing research training to extend adolescent HIV service from the clinic to the community. A multidisciplinary group of investigators, including four PhDs, will be trained in four priority adolescent health research areas including HIV prevention, HIV treatment, HIV/TB co-infection, and HIV and non-communicable diseases. The goal is to train the next generation of Haitian leaders at GHESKIO and the Haitian Ministry of Health who will conduct community-based research with the ultimate goal of improving health outcomes among adolescents and youth in Haiti.